Core C: Electrophysiology Core

Project Summary/Abstract
The Electrophysiology Core (Core C) will provide services for in vitro electrophysiological studies using novel
tools such as optogenetics and in vitro GCaMP6 calcium imaging. We will prepare brain slices, conduct patch-
clamp recordings, channelrhodopsin2 (ChR2)-assisted circuit mapping (CRACM), and Ca2+ imaging studies in
brain slices. The Core will also perform histology of the recorded slices and analyze the associated data.
Project 1 (Saper), Project 2 (Scammell), Project 3 (De Luca), and Project 4 (Vanderhost and Dymecki) will use
this Core facility. These projects are not equipped to conduct in vitro electrophysiology recordings, and there
are no institutional resources that can provide this service. These projects will benefit from the expertise and
shared resources provided by the Core.